Assessing the neural dynamics of reading in deaf adults

1
Poor literacy is a critical problem in the deaf population, but some deaf individuals do become skilled readers,
and they provide insights into the beneficial changes to the reading system that arise from successful
adaptations to distinct sensory and linguistic experiences. A deaf-specific neurocognitive profile for skilled
reading has been identified in adults, but the underlying mechanisms that give rise to this profile are unclear.
NIDCD’s strategic plan for 2023-2027 encourages research to “Examine the neural circuits and computations
that underlie multisensory interactions in communication processing and identify changes to these circuits
when compromised by sensory and communication deficits”. Supporting this objective, this project investigates
specific hypotheses about how early deafness impacts visual word recognition (e.g., via rapid visual
processing of orthographic features) and sentence-level processing (e.g., via enhanced attention to words in
the visual periphery). The project also investigates specific hypotheses about how linguistic differences (e.g.,
weaker phonological skills and the acquisition of a sign language, including fingerspelling) affect both word-
level processing (e.g., altering how orthographic representations are neurally represented and accessed) and
sentence-level processing (e.g., changing how semantic and syntactic information are weighted when reading
English). Because the processing of individual words is considered fundamental to reading, Aim 1 of the
project is to identify the mechanisms that underlie the unique neural dynamics of word reading in deaf adults,
but because typical reading involves multiple words encountered in connected text, Aim 2 is to characterize
the neural dynamics of sentence reading that are unique to skilled deaf readers. These aims will be achieved
through innovative methods that combine event-related potentials (ERPs) with state-of-the-art single word and
sentence reading paradigms, including co-registered EEG/eye-movement recordings during natural reading.
We also will use linear mixed effects regression to identify the effects of continuous measures of reading,
spelling, and phonological skills on ERP components using single trial EEG data. The results of this project will
advance our understanding of the neuroplasticity of the reading system and will be key to creating targeted
remediation programs for deaf adults with poor reading ability. By understanding the mechanisms that support
skilled reading in deaf people, individualized treatments and more precise interventions can be created that
target these mechanisms (promoting “precision medicine” – another goal of the NIDCD strategic plan), and
thus improve reading skills for this specific subpopulation.

Public health relevance
We live in a society for which reading skill is critical to health, economic success, and public engagement. However, for prelingually deaf individuals, reading presents a significant challenge because they cannot hear the language represented by print. This project aims to uncover the unique neurocognitive mechanisms that contribute to positive literacy outcomes for deaf people and thereby identify possible alternative pathways to reading success.